Aseto'ne Network Project: a multi-institutional initiative that will provide outreach, education, and mentoring activities to students at the nation's 36 Tribal Colleges and Universities.

Project Summary
The Aseto’ne Network Project is a broad, multi-institutional initiative designed to coordinate
outreach, educational enrichment, mentoring and personal development activities carried out at
the nation’s 36 Tribal Colleges and Universities (TCUs), the University of Nebraska Medical
Center, and national conferences focusing on American Indian and underrepresented minority
participation in STEM. These activities will engender and promote student interest and
engagement in health and biomedical research, building on health-focused programs and
initiatives which the TCUs currently offer or are involved with. The project is establishing a
network of professional researchers, faculty and students involved in mentoring, academic
enrichment, and personal growth-focused activities that develop and support student academic
and research-specific skills and interests, and inspire students to pursue a career as a health
sciences researcher. In the Cheyenne language Aseto’ne denotes the concepts of growth and
taking first steps. Thus, our project will provide the necessary steps and organizational
infrastructure to support Native students pursuing research careers and participating in building
a brighter future for themselves and for their communities.

Public health relevance
Project Narrative The Aseto’ne Network Project is a broad, multi-institutional initiative designed to coordinate outreach, education, and mentoring provided by the nation’s 36 Tribal Colleges and Universities (TCUs) and the University of Nebraska Medical Center (UNMC). Through the Aseto’ne Network Project, AIHEC and UNMC will coordinate our respective outreach and training resources, and our combined network of health sciences researchers and professionals to engage American Indian and Alaska Native students in a range of activities designed to encourage and support students to pursue health research careers. AIHEC, UNMC and our project partners will establish and promote interest and engagement in biomedical research among students attending all 36 TCUs. The project will establish a networked community of faculty and students involved in activities that develop students’ academic and research-specific skills, and promote an understanding of what is required to be a successful researcher. Most important, the project will reinforce in students the confidence in their ability to pursue a successful career in research.